OXIDATION PATHWAY FOR LDL BY MYELOPEROXIDASE:H2O2 SYSTEM OF ACTIVATED PHAGOCYTES

Many lines of evidence implicate oxidation of low density lipoprotein (LDL) in the pathogenesis of atherosclerosis, a chronic inflammatory disease. The physiologically relevant mechanisms have not been identified, but phagocytic white cells may play an important role because macrophage-rich lesions characterize the disorder. This article reviews the enzyme's ability to generate a range of oxidants, including tyrosyl radical, reactive aldehydes, hypochlorous acid and molecular chlorine. Production of such oxidants in vivo is reflected by formation of stable reaction products such as modified amino acids, as demonstrated by mass spectrometry. These products have the potential to damage host molecules as well as microbes, suggesting a mechanism that may contribute to atherosclerotic vascular disease.